Human sweat taste and contact-guided behavior in Aedes aegypti

PROJECT SUMMARY
Mosquitoes are responsible for transmitting disease to hundreds of millions of people each year. Behavior-
modification strategies have been major tools in surveillance and control efforts. A lot of attention has been
devoted to elucidating and manipulating detection of thermosensory and olfactory cues that drive host-seeking
behavior. However, a critical gap exists in our understanding of contact chemosensation in mosquito-host
interactions, despite the fact that biting and blood feeding behaviors are crucial factors in driving disease
transmission. After a mosquito has found a host, she lands on and examines the skin surface, and probes it
with her stylets before initiating a blood meal. It is well known that the human skin surface is replete with
chemicals, including those found in sweat. An understanding of whether human sweat cues can be sensed by
the mosquito taste system, and if so, whether these cues activate behaviors that precede initiation of blood
meals, would provide a valuable entry point for developing new behavior-modifying tools for surveillance and
control. Our model of choice is Ae. aegypti, a vector of Dengue, Chikungunya, and Zika viruses, which is
responsible for an enormous worldwide burden on human health, and is now also established in some regions
of the United States.
We propose to explore the hypothesis that soluble compounds present on human skin are sensed by the
mosquito taste system and activate close-range behaviors that precede blood feeding. We focus on human
sweat components, which include free amino acids in addition to salts, acids and ammonia derivatives. The
premise behind our hypothesis is supported by our pilot data, in which we find that an artificial sweat mixture
as well as certain individual amino acids and salt can activate taste neurons in female mosquitoes. Further,
mixtures presented on a filter paper target can stimulate interaction and probing attempts in mated females.
The specific goals of our proposal will be accomplished via two aims. In AIM 1, we will create a map of taste
responsivity of human sweat components and mixtures in the female Aedes aegypti mosquito. We will
determine if these stimuli promote residency or pre-feeding behaviors such as labellating and probing using
independent population-based and single-female behavior assays. In AIM 2, we will evaluate whether cellular
and behavioral responses to human sweat tastants are altered by knocking out selected taste receptors/co-
receptors using CRISPR/Cas9-mediated genome editing. The results of the proposed studies will provide
important molecular and neurophysiological insights into mosquito taste-guided behaviors elicited by
compounds found in human sweat.

Public health relevance
PROJECT NARRATIVE Prior to biting a human host, a female mosquito lands on and explores the skin surface, which is rich with chemical signals including non-volatile compounds found in sweat. We aim to improve our understanding of how human sweat is sensed by the taste system of the Aedes aegypti mosquito, which transmits deadly viruses including Zika, Dengue and Chikungunya. Our findings could facilitate development of new mosquito behavior modification strategies for surveillance and control.